The interplay between early-life enteric virus infection and the development of oral tolerance

PROJECT SUMMARY
Loss of mucosal tolerance is a major hallmark of digestive diseases, including inflammatory bowel
disease and celiac disease. Mucosal tolerance to dietary antigens develops during early childhood, a
time period that coincides with frequent enteric infections caused by viruses. One highly prevalent
cause of viral diarrhea is astrovirus, which infects the vast majority of children by the age of ten.
Although there is recent precedent for enteric viruses triggering a loss of tolerance to dietary antigens,
we lack a complete understanding of the underlying molecular mechanisms. There are currently two
main models for how enteric viruses trigger a break in tolerance– the first is through viral molecular
mimicry of a dietary antigen and the second involves bystander activation of immune cells, both of
which lead to inappropriate inflammation that can disrupt tolerogenic responses. In this proposal we
aim to evaluate a third model that centers around the role of goblet cell-associated antigen passages
(GAPs), which have been shown to be the primary pathway for establishing tolerance in the gut. Using
the murine model for astrovirus, this proposal will examine how this goblet cell-tropic virus impacts the
ability of GAPs to mediate tolerance to the dietary antigen, ovalbumin. In Aim 1, we will use T cell
conversion assays and robust measurements to determine whether astrovirus infection leads to a loss
of tolerance. We will also pioneer the use of spatial transcriptomics to determine how astrovirus
infection alters the cross-talk between infected GAP-forming goblet cells and antigen presenting cells in
the lamina propria. In Aim 2, we will test whether GAPs are co-opted by astrovirus to establish infection
or aid immune evasion. Completion of these proposed aims will provide the first mechanistic insights to
the role of GAPs during enteric virus infection and the consequences of infection on the ability of goblet
cells to mediate tolerance. Together these studies will define an entirely new facet of astrovirus
pathogenesis and initiate new lines of investigation into how enteric viruses contribute to the risk of
digestive disease.

Public health relevance
PROJECT NARRATIVE The main purpose of the proposed research is to examine the interplay between early childhood enteric virus infection and the development of mucosal tolerance. Because a loss of mucosal tolerance is a major hallmark of gastrointestinal diseases, including celiac disease, these studies are highly relevant to public health. By using a combination of robust models and cutting edge technologies, including spatial transcriptomics, we will fulfill a major priority of NIDDK that supports research on digestive diseases.